Tracking HIV Infection & Alcohol Abuse CNS Comorbidity with Neuroimaging

ABSTRACT
This application will build on and enable novel extension of our established program of study (R01AA017347),
"Tracking HIV Infection & Alcohol Abuse CNS Comorbidity with Neuroimaging." The current proposal seeks
neural substrates that accelerate brain structural and functional age-related declines in people living with HIV
infection (HIV), especially those who meet criteria for Alcohol Use Disorder (AUD). Particular attention is paid
to MRI-visible anomalies of white matter hyperintensities (WMH) and non-heme iron deposition that commonly
occur in normal aging and may interact with disease. WHM, markers of edematous tissue potentially marking
demyelination, are more prevalent among older individuals with HIV infection and even greater in those
comorbid with AUD relative to normal aging and may contribute to motor and cognitive deficits. Similarly, non-
heme iron deposition in subcortical and cerebellar dentate nuclei increases with age and may underlie
disturbance in gait and balance. Whether balance stability and cognitive abilities follow parallel or accelerated
aging trajectories in HIV with or without AUD comorbidity and are related to common brain markers remain
unclear. Herein, we propose a longitudinal protocol in using a suite of neuroimaging approaches to identify
mechanisms of local tissue degradation we hypothesize underpin functional declines in postural stability, gait,
and cognition of men and women aging with HIV infection and AUD. Longitudinal study of this population will
determine if the brain and behavior deficits are stable or accelerating, i.e., exhibit an age-disease interaction.
Specific Aim 1: White Matter Hyperintensity (WMH) volumes, detected with structural MRI using FLuid-
Attenuated Inversion Recovery (FLAIR) imaging, will be quantified and distinguished as periventricular
(PVWMH) or deep (DWMH) in cortical lobar, brain stem, and arterial regions.
Specific Aim 2: Myelin Integrity and Regional Iron Deposition will be measured with Quantitative
Susceptibility Mapping (QSM) and Diffusion Tensor Imaging (DTI). Non-heme iron will be quantified as
paramagnetic positive susceptibility in subcortical gray matter structures (globus pallidum, caudate, putamen,
red nucleus, dentate nucleus ). QSM diamagnetic negative susceptibility in combination with DTI will be used to
characterize tissue constituents in white matter tracts and WMH.
Specific Aim 3: Static Postural Stability, Dynamic Gait, and Cognition. Static postural stability will be
measured with a balance platform yielding metrics of sway path length, sway direction, and truncal tremor. Gait
will be video recorded and measured in-house yielding metrics of dynamic gait coherence and stability.
Standardized HIV-Associated Neurocognitive Disorder (HAND) composite scores will measure component
processes of cognition: executive function, working memory/attention, verbal and visual memory and learning,
and spatial abilities. Impact of WMH volume, regional iron deposition, and myelin disruption will be tested with
our static and dynamic measures of postural stability and with component processes of cognition.

Public health relevance
NARRATIVE With successful treatment of human immunodeficiency virus (HIV) infection, many people with HIV are now living a normal lifespan and advancing toward ages when physical and cognitive declines emerge. It is not known, however, whether treated HIV infection carries a liability for accelerated aging and signs of frailty or whether common comorbidities, notably alcohol use disorder (AUD), contribute to further decline. Elucidation of brain alterations associated with cognitive and motor deterioration in people aging with HIV will advance our understanding of underlying pathology and lend insight into prevention and treatment.